Targeting Succinate Signaling for Innovative Pain Relief in Oral Cancer.

Current pain management strategies for patients with oral or head and neck cancer conditions often rely on
high-dose opioid analgesics, which can be ineffective. Succinate is a dicarboxylic acid metabolite in the Krebs
cycle, and emerging evidence highlights its pro-inflammatory role through the activation of its G-protein
coupled receptor, SUCNR1. Notably, oral cancer patients show elevated circulating succinate levels and
increased SUCNR1 expression in tumor tissues.
We have been at the forefront of investigating succinate/SUCNR1 signaling and have demonstrated that
SUCNR1 activation prompts pro-inflammatory signaling in myeloid cells. Our preliminary findings indicate that
patients with oral cancer experiencing higher pain scores have elevated plasma succinate levels. Additionally,
SUCNR1 expression has been observed in both human and mouse ganglia, with succinate increasing
inflammation and nociception in wildtype (WT) mice but not in SUCNR1 knockout (KO) mice. In an MOC2
orthotopic xenograft model of oral cancer, KO mice exhibited reduced facial nociception and fewer tumor-
infiltrating myeloid cells.
We hypothesize that inhibiting SUCNR1 activation could alleviate oral cancer pain by reducing inflammation
and nociception. To test this hypothesis, we propose two specific aims.
In Aim 1, we will investigate succinate signaling and assess SUCNR1 as a potential target for alleviating oral
cancer pain using clinical samples and preclinical models. The analgesic effects of a novel SUCNR1
antagonist we have developed will be evaluated in 4NQO-induced oral cancer mice. We will measure tumor
growth, oral function, and referred mechanical and thermal hypersensitivities, along with associated
comorbidities. Additionally, we will explore the distribution and neuromodulatory function of SUCNR1 in
human oral cancer tissues, and the ganglia of both human and mouse.
In Aim 2, we will evaluate the role of myeloid SUCNR1 in oral cancer pain with global and myeloid-specific
knockout mice, alongside their littermate controls. Three oral cancer models—MOC1 and MOC2 orthotopic
xenografts and 4NQO-induced oral cancer—will be developed in these mice. We will measure tumor growth
and nociception while characterizing various myeloid populations in tumor, peripheral blood, and tumor-
draining lymph nodes through flow cytometry. Lastly, we will assess succinate and cytokine levels in serum,
and tumor tissues using succinate assays, Meso Scale Discovery multiplex immunoassays, and semi-
quantitative PCR.

Public health relevance
Narrative Our research aims to uncover a new mechanism of inflammatory pain and nociception in oral cancer, regulated by succinate and its receptor. We will evaluate the analgesic effects of a specific succinate receptor antagonist we’ve developed, testing it as a non-opioid therapeutic option for managing pain associated with oral cancer.